Prebiotic Activity of Pinto Beans Reduces Neuroinflammation in Estrogen Deficiency

Project Summary/Abstract:
The prevalence of of Alzheimer’s disease (AD) is 2–3 times higher in post-menopausal women and pathology progression
and memory impairment is worse in women than men. The rapid decline in circulating estrogen in postmenopausal
women has been proposed as a trigger for the development of AD in this population. Previous studies have established a
relationship between circulating estrogen levels, gut health including gut microbial population, and brain function.
Estrogen deficiency-associated microbial dysbiosis is associated with reduced diversity of gut bacteria (i.e., bacteria with
β-glucuronidase activity) that can deconjugate estrogen-containing compounds including phytoestrogens as well as those
involved in the production of short chain fatty acids (SCFAs) and tryptophan (Trp) metabolites. Recent studies have
identified the influence of SCFAs as well as Trp metabolites in the stimulation and maintenance of brain function. Our
parent project is designed to investigate the mechanism through which pinto bean (PB) modulates cardiometabolic
outcomes in a mouse model of estrogen deficiency. In this administrative supplement application, we propose to extend
that work by examining the effects of PB on the gut-brain axis and subsequent effects on the prevention of
neuroinflammation associated with AD in estrogen deficiency, much like the at-risk postmenopausal population. We
hypothesize that PB, due to its many bioactive compounds, particularly its Trp and resistant starch (RS) content, will
modulate gut microbial composition to maintain gut integrity and increase the production of gut-derived metabolites (i.e.,
SCFAs and Trp metabolites) consequently improving gut health, reducing neuroinflammation and slowing down the
progression of AD in estrogen deficiency. This hypothesis will be tested by: Aim 1: determining the effects of PB and RS
on gut microbial composition and gut-derived metabolites and their subsequent effects on markers of neuroinflammation
in estrogen deficiency; and Aim 2: investigating the role of β-glucuronidase inhibition combined with PB in the
prevention of neuroinflammation in estrogen deficiency. The proposed supplemental study will expand the scope of our
current R15 and will now focus to include both metabolic outcomes and prevention of AD in estrogen deficiency. Both
studies will provide extensive training opportunities for graduate and undergraduate students, and cross-training between
the field of nutrition and brain physiology. Our findings will help advance our understanding of how foods with prebiotic
properties such as PB promote health and prevent diseases. Our findings will also help lay the groundwork for future
clinical studies, in line with our long-term goal of developing economical, safe and effective strategies for disease
prevention.

Public health relevance
Project Narrative: This supplemental study will examine if a commonly consumed food, the pinto beans, will reduce neuroinflammation associated with Alzheimer’s disease in a mouse model of menopause. We are examining if changes in gut bacterial population and their products due to pinto bean consumption will improve gut integrity which will consequently reduce neuroinflammation, protect the brain, and slow down the progression of Alzheimer’s disease in a model of estrogen deficiency. Findings of our study will provide postmenopausal women, a group that is at an increased risk for Alzheimer’s disease, an economical, safe and effective approach for preventing this debilitating disease.